Rv3802c function in mycobacterial cell envelope remodeling, barrier properties, and antibiotic susceptibility

Project Summary/Abstract
A quarter of the global population is infected with Mycobacterium tuberculosis, the causative agent of
tuberculosis (TB). TB and other mycobacterial diseases are difficult to fight with immune responses or antibiotic
therapy, largely due to the unique structure and composition of the mycobacterial cell envelope. The
mycobacterial cell envelope contains more layers and more diverse lipids than other bacterial cell envelopes,
which provides intrinsic resistance to common antibiotics that can treat other bacterial infections. To fight TB,
we need therapeutic strategies that can overcome the unique barrier properties of the mycobacterial cell
envelope. We therefore need to understand how to rationally disrupt that barrier. My project will address this
need by using Rv3802c as an archetype to study the connection between biological function and the
phenotypes of membrane properties and antibiotic susceptibility. Rv3802c is an essential protein with a
putative role in cell envelope biosynthesis. I hypothesize that Rv3802c remodels the cell envelope to allow for
the deposition of new cell envelope material, and that depletion of Rv3802c will decrease membrane fluidity
and permeability to solutes and antibiotics. The goals of my project are to (1) characterize the biological
function of Rv3802c and (2) determine Rv3820c’s role in regulating membrane barrier properties and antibiotic
resistance. Connecting cell envelope biosynthesis to membrane barrier properties and antibiotic susceptibility
will help fill in a vital gap in knowledge, ultimately paving the way for rational design of novel drugs and
synergistic drug combinations.

Public health relevance
Project Narrative Mycobacterium tuberculosis infects a quarter of the global population and the prevalence of multidrug resistant strains of Mycobacterium tuberculosis is on the rise. Understanding Mycobacterium tuberculosis physiology and identifying the pathways involved in antibiotic resistance are key to developing novel anti-tuberculosis drugs. This research is relevant to the NIAID mission to support basic research that advances our understanding, treatment, and prevention of infectious diseases.